In Vitro Reconstitution of Centralspindlin-Mediated Transport

Project summary/abstract
This proposal aims to address the knowledge gap in our understanding of the molecular mechanisms through
which centralspindlin regulates cytokinesis. Cytokinesis is the last act of cell division, in which cleavage furrow
ingression produces physically distinct daughter cells. Errors in cytokinesis can lead to cancer. During
cytokinesis, centralspindlin, a motor protein complex, is crucial for the localization of key furrowing components
and other proteins to the site of cleavage furrow formation. Although previous in vivo studies have highlighted
centralspindlin’s essential role, the exact mechanisms remain unclear. We propose to clarify these through the
in vitro reconstitution of centralspindlin-mediated transport. The overall objective of this project is to define the
molecular mechanisms through which centralspindlin transports required cargos along microtubules to direct
furrow formation. Our lab has established conditions to stably express full-length centralspindlin and developed
methods for the in vitro reconstitution of centralspindlin-mediated transport. Our long-term goal is to
reconstitute cytokinesis using purified centralspindlin and other regulatory components. Our central hypotheses
is that centralspindlin-mediated transport along microtubules is a regulated mechanism to localize the
components that direct furrow formation and cytoplasmic abscission. We will test our hypothesis by identifying
the features of centralspindlin required for robust microtubule plus-end localization, determining the target
cargos transported by centralspindlin, and exploring the factors that regulate centralspindlin-mediated
transport. This study is innovative because it employs novel methods to address previously unresolved
questions about centralspindlin. The project is significant as it will provide a precise understanding of
cytokinesis and offer new potential targets for cancer treatments. Additionally, this project will help establish a
research community of underrepresented minority students through my laboratory at the University of Hawaii at
Hilo, the most ethnically diverse campus among national universities.

Public health relevance
Public Health Relevance Statement Cytokinesis, the final step in mitosis, is the last opportunity to regulate cell division and is often disrupted in cancers. This process is regulated by a protein complex known as centralspindlin that localizes key regulatory proteins to the site of the cytokinesis furrow. The goal of this project is to directly address the gap in our understanding by studying the mechanisms of centralspindlin-mediated transport, potentially identifying new targets for anti-cancer therapies.